Functional roles of mTOR in tumor persistence

PROJECT SUMMARY
The mTOR pathway is a master regulator of nutrient metabolism and cell proliferation in response to
environmental cues. It has long been viewed as an important driver of tumorigenesis and an ideal cancer
therapeutic target. Multiple mTOR inhibitors have been tested in more than 500 clinical trials, either as
single agents or in combination with chemotherapy for cancer treatment. However, among nearly 200
completed trials, few show positive outcomes, challenging the utility of mTOR as an effective cancer
therapeutic target. As an integrator of extracellular signals and cellular responses, the mTOR pathway is
critical for cellular adaptation to environmental changes. In particular, mTOR inhibition induces embryonic
diapause, a reversible dormancy state in development in response to unfavorable environment cues. We
reason that, analogous to its role in embryonic diapause, mTOR inhibition may induce an adaptive
diapause-like dormant state in cancers, leading to the persistence of residual tumors following
chemotherapy. In line with this notion, recent studies have indeed reported markedly reduced mTOR activity
in residual tumors. However, a causal relationship between mTOR inhibition and tumor persistence has not
been established or investigated. Integrating multiple state-of-the-art approaches, our recent studies show
that mTOR inhibition indeed induces a diapause-like persister state in tumor cells. We confirm that this is a
pan-cancer phenomenon using tumors from diverse tissue origins and demonstrate that the persister state
recapitulates the residual tumors in patients following chemotherapy. Importantly, our studies identify
ferroptosis as a key druggable vulnerability of persisters. Built on these compelling findings, we
hypothesize that mTOR is a master regulator of a diapause-like persister state in tumors by modulating
survival and dormancy. The current proposal aims to investigate the mechanistic regulation of the persister
state, and test therapeutic strategies to target residual tumors in preclinical models, with the ultimate goal
to prevent tumor recurrence in patients.

Public health relevance
PROJECT NARRATIVE The mTOR pathway is a master regulator of nutrient metabolism and cell proliferation in response to environmental cues. Elucidating the mechanistic role of mTOR in regulating tumor cell dormancy and persistence is critical for clinical treatment of many human cancers.